Interactions Between the Microbiota and Helicobacter pylori in Gastric Carcinogenesis

Summary
This multi-Pl R01 is submitted in response to NCI FOA PAR-20-062 Co-infection and Cancer and includes
2 seasoned, collaborative Pis with complementary expertise in microbial carcinogenesis (Richard Peek and
James Fox). H. pylori confers the highest known risk for gastric adenocarcinoma. However, studies by the CoPis
and others have demonstrated that gastric microbiota populations affect cancer risk in synergy with H. pylori.
We have full access to a unique longitudinal, prospective human cohort in Colombia where gastric
adenocarcinoma and H. pylori infections are endemic. Full clinical, endoscopic, and histologic data are available
at baseline and at each interval follow-up out to 26 years, including frozen gastric tissue for microbiota analysis
and culture from the 20- and 26-year timepoints from persons who either progressed histologically or
remained stable, providing a unique opportunity to define disease mechanisms. We also have access to
prospectively obtained gastric tissue from patients at Stanford with or without premalignant lesions, allowing us
to extend these studies into a US population. Our laboratories have developed models that closely recapitulate
the gastric niche to define mechanisms of carcinogenesis within the context of H. pylori and the microbiota. Dr.
Fox has utilized germ-free (GF) INS-GAS mice to demonstrate 1) H. pylori accelerates carcinogenesis in mice
harboring a gastric microbiota compared to GF mice, and 2) colonization with bacteria differentially represented
in high vs. low cancer risk populations modifies the ability of H. pylori to induce gastric injury. Dr. Peek has
developed complex primary gastroid:macrophage:T cell systems to demonstrate that H. pylori drives oncogenic
signaling in a cell- and strain-specific manner and that non-H. pylori gastric species successfully colonize these
models. Collectively, our scientific scope, available resources including cutting-edge metabolomics, and
innovative model systems will allow us to fully address the hypothesis that progression to gastric cancer is
influenced not only by H. pylori virulence constituents, but also by prolonged interactions with members of the
gastric microbiota. which can modulate immune responses. We will address this hypothesis via these Aims.
Aim 1: Identify and define components of the gastric microbiota in persons who did or did not progress towards
gastric cancer using Whole Metagenome Shotgun (WMS} sequencing
Aim 2: Utilize innovative ex vivo systems to define the carcinogenic potential of gastric microbiota species and
prioritize candidates for more definitive in vivo studies of gastric cancer
Aim 3: Utilize novel germ-free rodent models and metabolomics to define causality of high priority gastric
microbiota species and corresponding immune responses linked to disease progression within the gastric niche

Public health relevance
Project Narrative These studies will define mechanisms and identify people who are at greatest risk for gastric cancer, which will greatly improve the diagnosis and management of this disease.